Reducing slip-and-fall accidents in the workplace: Role of small-scale roughness of floor surfaces to improve friction

Project Summary
Fall-related injuries burden over 140,000 workers annually, causing significant human suffering and an
economic cost of $10 billion in Workers' Compensation. Approximately half of occupational falls are caused by
slipping. An under-explored pathway to preventing these slip-and-fall events is to design flooring for
workplaces with high friction performance. High-friction flooring prevents the slip events that lead to a fall.
Unfortunately, current methods to characterize floor-surface topography are unable to predict friction
performance, limiting innovation in this area. In order to catalyze innovation in high-friction flooring, there is a
need for improved scientific understanding of the flooring factors that contribute to friction. Our preliminary
studies and existing literature suggest that small-scale topography (features at the 1-nm to 1-µm scale) is
critical for predicting floor performance, but is not measurable using conventional characterization techniques.
The purpose of this R21 project is to measure these small-scales of floor-surface topography, and to use them
to develop a mechanics-based predictive model for friction. This research is innovative because it will employ
novel experimental methods and analysis techniques that have never been applied to flooring surfaces, and
because it will develop a mechanics-based model to predict the relationship between floor structure and friction
performance, where prior research has relied solely on empirical correlations. The proposed research will be
accomplished through two Aims:
Aim 1: Quantify the dependence of shoe-floor friction performance on small-scale topography. This Aim
will investigate the ability of small-scale topography to explain variations in shoe-floor friction performance that
cannot be explained using current measurement techniques. Then we will test the first hypothesis: Hypothesis
1: Roughness parameters that consider the full range of scales will improve our ability to predict COF values
compared with those using just stylus profilometry.
Aim 2: Establish a predictive mechanics-based model for shoe-floor friction based on multiscale
surface topography. In this Aim, we will develop and validate a multiscale finite element model that captures
viscoelastic contributions to friction across all length scales. We will test the second hypothesis: Hypothesis 2:
A mechanics-based model using multiscale topography will more accurately predict shoe-floor friction
compared with conventional approaches, i.e., statistical models based on stylus profilometry.
This research is expected to lead to foundational knowledge and a modeling tool for optimizing high-friction
flooring in workplaces. Working with an industry trade group, the Tile Council of North America (TCNA), this
research will achieve impact by guiding the evidence-based development of high-friction flooring for
workplaces. Thus, the proposed research is expected to achieve impact in improving workplace safety.

Public health relevance
Project Narrative Slip-and-fall accidents are a significant source of workplace injuries. An urgent need exists to develop experimental techniques and tools that can predict friction performance based on flooring design. This project will apply new surface characterization approaches and develop a novel mechanics-based model to improve prediction of shoe-floor friction based on small-scale topography. Thus, this research is expected to lead to new flooring interventions that significantly reduce the prevalence of slip-and-fall injuries in workplaces.